microRNA-dependent regulation of intestinal T-cells²

Project Summary
Our intestines comprise over 50% of our bodies immune cells and tightly maintains a constant state of
homeostasis against foreign stimulus like food particles and bacteria. This immune “tolerance” is broken during
chronic intestinal inflammation as seen during inflammatory bowel diseases (IBD). Adverse CD4+ THelper
responses perpetuate the chronic pathology observed in IBD, thus understanding the molecular mechanisms
that control their function is central to endeavors of finding novel therapeutic treatments. A physiologic adaptive
response to inflammation is a marked shift in the supply and demand of metabolites that results in limited
oxygen availability (now termed inflammatory hypoxia) and activation of the transcription factors hypoxia-
inducible-factors (HIFs). While there are multiple affects of hypoxia on T cell gene function, the effects on post-
transcriptional regulation are underexplored. To investigate hypoxia-elicited tissue protective signaling we
performed a screen of CD4+ T cell-specific miRNAs and identified a selective induction of miR-29a. Studies
with genetic models identified a role of Hif-2α in miR-29a induction and subsequent experiments demonstrated
repression of the miR-29a target-genes Tbet and IFNγ (canonical TH1 markers) during hypoxia. Mice with a T-
cell-intrinsic deficiency in Hif-2α displayed elevated Tbet levels in CD4+ T cells and exacerbated inflammation
during experimental colitis. Based on these preliminary studies, we hypothesize that Hif-2α induction of miR-
29a suppresses TH1 CD4+ cell activation. In this proposal we will address this hypothesis with three integrated
lines of investigation. Firstly, we will examine how Hif-2α transcriptionally induces miR-29a and the functional
requirements for Hif-2α in CD4+ THelper differentiation. Second, we will assess the role of miR-29a in the
regulation of T cell mediated colitis. Lastly, in proof of concept studies we will target miR-29a stabilization in
vivo during experimental colitis. Collectively these studies aim to dissect the Hif-2α-miR-29a-Tbet axis in the
regulation of CD4+ T cell-mediated intestinal inflammation.!
!

Public health relevance
Project Narrative Auto-reactive CD4+ Helper T cell subsets play a central role in the pathogenesis of inflammatory bowel disease. The main goal of this research proposal is to understand how the inflamed intestine regulates CD4+ TH1 T cells via miRNAs. These studies will test how miR-29a tapers the inflammatory tone of gut-infiltrating CD4+ T cells during experimental inflammatory bowel disease (IBD). Our intended studies will provide novel insight into the endogenous microRNA-mediated mechanisms responsible for the regulation of adaptive immune responses in the intestine during IBD.